Core B: Clinical Trials and Statistics

Clinical trials and Statistics Core
Project Summary
The Clinical trials and Statistics Core (Core B) Resource will collaborate and provide comprehensive statistics
service and infrastructure support for clinical trials to all Research Projects in this proposed Program Project
Grant. In addition, it will provide support for data management and integration, informatics, and computing, and
assist with the identification and solution of complex data tasks arising in the course of project activities. Core
members will work with project investigators across a wide spectrum of activities, encompassing formulation of
the study design, data acquisition, statistical quality control, clinical trial monitoring, data analysis and
interpretation, abstract and manuscript preparation, and data dissemination. Furthermore, when required by a
specific project, Core personnel will develop and implement innovative customized biostatistics methodologies
and tools in collaboration with investigators in the P01. The Core B Resource is housed in the Division of
Biostatistics and Bioinformatics, Department of Oncology at Johns Hopkins University School of Medicine. This
Division comprises an active and committed group of biostatistics and bioinformatics faculty, as well as non-
faculty biostatisticians and bioinformaticians, with access to state-of-the art equipment and a broad range of
expertise. Core members have a strong commitment to this P01, stemming from their long-standing
collaborations with the Gastrointestinal Cancers Program. All proposed Projects make use of this Core
Resource in every Aim.
The primary objective of Core B is to guide and assist the project investigators in the design, conduct, and
analysis of the laboratory, translational and immunologic correlative studies, and clinical trials proposed in this
P01. Each project has a primary biostatistician thoroughly versed in the subject matter associated with the
project, and all projects have access to the breadth of expertise provided by Core personnel. Core members
also interact on a regular basis, and work closely with Administrative Core A and Genomic and Bioinformatics
Core C, which contributes to interactions and synergy among the projects.

Public health relevance
Project Narrative The Clinical trials and Statistics Core (Core B) serves as a centralized resource to all pancreatic cancer P01 program investigators and promotes synergy across different projects and resources. It enhances the abilities of projects to address key scientific questions that will lead to a reduction in the morbidity and mortality associated with pancreatic cancer. The work of Core B is to ensure that clinical and laboratory studies are carried out using sound designs, and the results analyzed with appropriate methods in order to reach justifiable scientific conclusions.